Role of the Factor H Related Proteins in Kidney Disease

The complement system plays an important role in a diverse spectrum of kidney diseases, including
autoimmune glomerulonephritis as well as many conditions not traditionally thought of as immune-mediated.
Factor H (FH) is a centrally important complement protein in the blood that serves as a major regulator of
complement activation in both the fluid phase as well as on cell surfaces and interstitial matrices. Factor H-
related proteins (FHRs) comprise a structurally related family of five genes in humans which have recently
been identified as key pathogenic drivers of human kidney diseases by acting as modulators of complement
and/or FH function. However, the functions of the FHRs are complex and controversial. In addition, animal
models of individual FHR deficiency and FHR protein-specific monoclonal antibodies (mAbs) were not
previously available for evaluating the in vivo roles of these proteins. Our proposal addresses this important
knowledge gap. The overall hypothesis of this project is that individual FHRs competitively antagonize or
otherwise modulate FH function and complement activation on specific surfaces in the kidney, and this has
a profound effect on complement-mediated inflammation at these sites. Furthermore, by interfering with C3d-
receptor interactions, the FHRs also have a strong effect on the upstream immune response to self and
foreign antigens. To test this hypothesis we propose the following specific aims. Aim 1. Examine the functions
of the different FHRs on distinct kidney surfaces. We have developed a “toolbox” for studying the FHRs in
the kidney, including mice with targeted deletion of the individual FHRs, recombinant forms of the FHRs, and
monoclonal antibodies to the FHRs. We will use these tools to map the interactions of the FHRs with healthy
and diseased kidneys. Aim 2. Examine the roles of individual murine FHRs in the development of
autoimmunity. We will use panel of FHR deficient mice to study the effects of these proteins on the
development of antibodies to self and foreign antigens. Aim 3. Examine the role of the FHRs as downstream
mediators of kidney inflammation. We will use FHR-deficient mice and recombinant FHR proteins to examine
the role of the FHRs in causing complement dysregulation in glomerular and tubulointerstitial diseases. The
studies in this proposal are innovative, because they utilize novel reagents and approaches to examine the
function of the FHRs. This project is significant, because will improve our understanding of a family of proteins
that are poorly understood but that have been linked with several different diseases.

Public health relevance
The proposed research is relevant to public health because autoimmune and inflammatory kidney diseases are a significant cause of morbidity and mortality in affected patients. Standard immunosuppressive drugs are not effective in many patients, and the drugs themselves are associated with significant side effects. The concepts tested in these experiments should offer an important new approach to treating these diseases.